Promoting cognitive resilience and reducing frailty in older Veterans with bright light therapy

Promoting cognition and reducing frailty in older Veterans with bright light therapy
Frailty is a multifactorial syndrome characterized by vulnerability to stressors that increases
disability and mortality risk. Thirty percent of Veterans 65 years or older are frail, which is three-times
higher than aged matched non-Veterans. Frailty is intricately linked with cognitive impairment and
Veterans are particularly susceptible with 14 percent exhibiting cognitive decline, some with early onset
as young as 45 years of age. Importantly, 70% of frail and cognitively impaired older adults exhibit sleep
disturbances, which makes identifying and improving sleep quality an attractive therapeutic strategy to
enhance healthspan. Furthermore, this is of special interest as 55% of older Veterans experience sleep
disturbances. The goal of this study is to examine the feasibility of utilizing bright light therapy (BLT)
as a strategy to improve sleep via reduction of circadian rhythm disturbances. The long-term goal is to
assess the potential for improving cognition and reducing frailty in older Veterans. BLT works by
resynchronizing the hypothalamic biological clock via brief exposure to specific wavelengths of light
following awakening, which restores melatonin and circadian rhythms. However, BLT has not been
examined for reducing frailty in older Veteran populations. This project will therefore lay the foundation
for larger trials the evaluate BLT in the treatment and prevention of cognitive disorders and to promote
healthy aging.

Public health relevance
Frailty is a multifactorial syndrome characterized by vulnerability to stressors that is intricately linked to cognitive impairment and mortality risk. Bright light therapy (BLT) reduces circadian disturbances by resynchronizing the hypothalamic biological clock via specific wavelengths of light. Human trials have demonstrated that BLT improves sleep quality and cognitive function in older adults. However, BLT has not been examined for use in older Veteran populations, particularly the impact on frailty. This randomized trial will assess the feasibility of employing BLT to study impacts on frailty, cognition, and sleep in older Veterans. Findings from this pilot will establish the power and effect size necessary for larger trials to support the use of BLT as readily available home-based treatment to improve healthspan of our Veterans.